NTSHSD2 neuron activity: regulation by aldosterone and afferent control”

PROJECT SUMMARY/ABSTRACT
NTSHSD2 neurons are activated by aldosterone and detect sodium deficiency. When activated, NTSHSD2
neurons drive robust sodium appetite, while their ablation reduces intake. As key regulators of sodium appetite,
how NTSHSD2 neuron activity is controlled is of great interest. During sodium deficiency or mineralocorticoid
excess, NTSHSD2 neurons exhibit increased spontaneous activity in ex vivo brain slice recordings, which we
hypothesize is mediated by aldosterone-mineralocorticoid receptor (MR) signaling. However, the molecular
mechanisms through which aldosterone-MR signaling acts to drive NTSHSD2 neuron activity are unknown.
Further, sodium ingestion has been shown to rapidly decrease Fos expression by NTSHSD2 neurons, indicating
active inhibition of NTSHSD2 neurons. Such rapid control is likely to be mediated by neural input, but the specific
afferent neurons that regulate NTSHSD2 neuron activity are yet to be elucidated. The goal of this grant is to
study mechanisms by which NTSHSD2 neuron activity is controlled. Aim 1 will determine how aldosterone-MR
signaling regulates NTSHSD2 neuron activity. We propose a key role for genomic regulation by aldosterone-MR
signaling for driving intrinsic activity of NTSHSD2 neurons during sodium deficiency and mineralocorticoid
excess. Aims 2 and 3 will define the wiring diagram of inputs to NTSHSD2 neurons as these very afferents are
also likely sensitive to alterations in extracellular fluid volume and/or sodium intake. This will be accomplished
through single cell transcriptional profiling of NTS afferent neurons to identify their marker genes, which will
then be leveraged to gain access to the afferent neurons using Cre driver mice. Connectivity to NTSHSD2
neurons will then be established by performing channelrhodopsin-2 (ChR2)-assisted circuit mapping (CRACM).
Finally, we will also specifically investigate regulation of NTSHSD2 neurons by the central amygdala (CeA) – a
GABAergic structure linked to appetite control with neurons that provide input to NTSHSD2 neurons. Our goal is
to identify the information carried by these afferents and their effects on sodium appetite. The experiments
proposed in this project will address significant gaps in our knowledge regarding the regulation of NTSHSD2
neurons by providing both molecular and circuit mechanisms for the control of their activity.

Public health relevance
PROJECT NARRATIVE The link between sodium intake and blood pressure is well-established. As a result, reduction in dietary sodium intake is recommended; however, these recommendations have largely failed. This project will investigate the neural circuits that drive sodium intake.